EFFECT OF AN ELEMENTAL DIET, VIVONEX PLUS, ON REFRACTORY POUCHITIS

The goal of this study is to establish effective treatment for inflammation of the ileal pouch-anal anastomosis in patients with ulcerative colitis.